PROMOTE and TEACH Equity

ABSTRACT
Minoritized pregnant patients sometimes face impossible choices between earning necessary income and
adherence to prenatal care; these issues were highlighted in our formative qualitative work with Black pregnant
patients. Increased prenatal care adherence and positive maternal and infant health outcomes may be promoted
by addressing work-related pregnancy care barriers. Obstetric clinicians are uniquely positioned to ensure
pregnant patients are educated about federally mandated employment protections during their pregnancy,
however very few clinicians have formal training about employment laws that govern accommodations during
pregnancy and postpartum. To fill this unmet need, a patient- and community-engaged multidisciplinary team
and I developed, and pilot tested PROvider ReMote ObsTetric-Related Employment Education (PROMOTE).
Our research aims will use a clinic-level randomized trial comparing PROMOTE vs usual care. During Research
Aim 1, we will determine the efficacy of PROMOTE to increase the likelihood that obstetric clinical teams counsel
patients about work and pregnancy. In Research Aim 2, we will determine the effectiveness of PROMOTE to
reduce undesired wage or advancement reduction, increase access to accommodations, and improve prenatal
care adherence and pregnancy health outcomes. The rich dataset that we will collect, including electronic
medical record review, patient survey and qualitative interviews will be leveraged as we advance our Diversity,
Equity, Inclusion, and Accessibility (DEIA) work. Our DEIA work will enhance diversity in biomedical research
by developing and pilot testing ObsTetric HEAlth Equity ResearCH Mentoring (TEACH) Equity, a year-long
mentored career development and obstetric health disparities research program tailored to medical students
who are underrepresented in medicine. During DEIA Aims, the patient- and community-engaged multidisciplinary
stakeholder and I will develop the TEACH Equity mentorship program including career and research mentorship.
We will leverage existing institutional resources at Duke and integrate TEACH Equity seamlessly into the unique
Duke medical school curriculum which provides a year for mentored research. We will pilot test TEACH with six
Duke medical students to determine feasibility and acceptability of TEACH Equity. The proposed research and
DEIA work is led by an early-stage investigator clinically trained as a Maternal Fetal Medicine subspecialist with
master’s level research training, formal health disparities research training, local and national DEIA leadership,
and experience mentoring trainees underrepresented in medicine. The proposed project integrates research
that will yield an intervention that empowers obstetric clinicians with practical skills to address employment-
related barriers to prenatal care and DEIA work that will enhance diversity in biomedical research developing
and pilot testing an obstetric health disparities mentored research experience tailored for underrepresented
minority medical students.

Public health relevance
Project Narrative The proposed research is both relevant to public health and aligned with the National Institutes of Child Health and Human Development’s mission; we will test the efficacy of an intervention designed to improve maternal and infant health by empowering clinicians with skills to enhance patients’ access to continued gainful employment and accommodation to ensure a safe working environment during pregnancy. Data gathered during the randomized trial, including electronic health record review, patient survey and qualitative interviews will also be leveraged to support diverse medical students as they participate in a year-long mentored career development and obstetric health disparities research program. We will enhance diversity in biomedical research by conducting a rigorously designed trial in collaboration with a patient- and community-engaged multidisciplinary team while mentoring medical students poised to become the next generation of clinician scientists dedicated to eradicating health disparities in maternal and infant health.